Neural Circuits Underlying Post-operative Delirium in Early Stage Alzheimer's Disease

Postoperative delirium (POD) is a common and serious postoperative complication among the elderly, especially
those with Alzheimer’s disease (AD), and has no available treatments. Interestingly, the risk for POD begins at
preclinical AD stages when mild sustained attention deficits emerge. For this K99/R00, I will investigate the role
of the locus coeruleus and ventral tegmental area – two regions affected by AD pathology and inhibited by
general anesthetics – on the development of sustained attention deficits and POD using the rodent model of AD,
TgF344-AD. I have developed a variant of the 5-choice serial reaction time task, a touchscreen sustained
attention task, in which real-time cognitive recovery is assessed in rats following general anesthesia to capture
the severity and duration of POD symptoms. In Aim 1 (K99), I will characterize the progression of sustained
attention deficits in TgF344-AD and aging rats and its association with POD and AD histopathology. In Aim 2.1
(K99), I will use a novel dual-viral mediated chemogenetic targeting technique to establish the role of ventral
tegmental area dopaminergic neurons in AD-related attentional impairments. With these skills, I will be well-
equipped to independently pursue Aim 2.2 (R00), which applies the same techniques to investigate
noradrenergic locus coeruleus neurons in AD-related attention impairments, and Aim 3 (R00), where chronic
and acute activation of the ventral tegmental area and locus coeruleus will be used to mitigate AD-associated
POD. My overall career goal is to lead an independent research group examining the underlying neural circuits
impacting POD in AD with the long-term goal of creating interventional therapeutic strategies against dementia-
associated POD. To accomplish this goal, I will need additional training in chemogenetic techniques, transgenic
rodent models of AD, and AD neuropathology. For the K99 phase, I will have the guidance of my mentor, Dr.
Ken Solt, who will train me in chemogenetics, and co-mentor, Dr. Zhongcong Xie, an expert in AD and POD
research. My Advisory Committee, Drs. Christiane Wrann (AD transgenic model expertise) and Timothy Houle
(statistics expertise), will provide research and professional guidance as I near independence. My career
development plan integrates didactics in AD pathology and neuroengineering; training in communication, lab
management, and grant writing; and professional networking opportunities. Massachusetts General Hospital and
Harvard Medical School provide the ideal environment to conduct the proposed research, providing all the
facilities necessary within a supportive, collaborative team of researchers and clinicians. The protected time and
mentorship provided by this K99/R00 will allow me to acquire the technical and conceptual skills required to lead
a focused research program on POD and AD research as an independent investigator. The outcome of this work
will yield important insight into the role of neural circuits implicated in prodromal AD and aging and how they may
be targeted to prevent and treat POD.

Public health relevance
Project narrative Postoperative delirium is a common, costly, and potentially fatal complication that is strongly associated with aging, Alzheimer’s disease (AD), and other forms of dementia. The goal of the project is to establish the role of neural circuits affected early in AD and aging on prodromal cognitive function and risk of postoperative delirium using clinically relevant behavioral testing paradigms in a rat model of AD. The proposed studies implement chemogenetic tools to identify specific therapeutic targets for POD intervention.